METABOLIC DIFFERENTIAL BETWEEN BRAIN AND BRAIN TUMOR WITH THIOPENTAL

This project involves FDG-PET scanning of patients who have brain tumors before and during deep barbiturate general anesthesia. The results indicate that a profound reduction of cerebral glycolytic activity can be achieved with a level of anesthesia which produces burst-suppression EEG activity. Gliomas, however, have only a minimal change in glycolytic rate under the barbiturate anesthesia. The results also indicate that lower grade lesions, which are not visible on PET scans performed with the patient awake, become visible as background synaptic activity is suppressed with barbiturates. The true extent of growth into the surrounding tissue by higher grade lesions can be better appreciated when background activity is reduced under the barbiturate anesthesia. This work provides evidence that barbiturates may allow a "reverse contrast enhancement" of lesions with decreased neuronal activity. This phenomenon may provide a basis for development of specific antitumor therapy. The technique also may be valuable in studying other pathological processes such as degenerative diseases, epilepsy, movement disorders, cerebral infarction and head injury.